Effects of input quality on ASL vocabulary acquisition in deaf children

The goal of the parent grant is to broaden our understanding of how children learn language to be inclusive of
deaf children who are learning a sign language to communicate. This is important because it makes theories of
language acquisition more inclusive and because deaf children face systemic barriers in accessing and
learning language. The aims of the proposed supplement are threefold. First, it offers the PI of the grant
training in supporting scientists from diverse background. The training would cover topics including: setting
goals and expectations, culturally aware and inclusive mentoring, giving feedback and navigating difficult
conversations, and interrupting interpersonal violence. The second aim is to create professional development
materials for scientists in ASL. There are many resources to support professional development available for
scientists who use a spoken or written language, but very few resources exist in ASL. The PI has developed a
host of trainings on a variety of subjects that have been offered in house. The proposed supplement would
support filming and publishing these materials in ways that scientists across the country could easily access at
any time. The third aim of the proposal is to support postdoctoral training for Kaj Kraus, a queer deaf scientist,
who would help carry out Aim 3 Study 6 from the parent grant.

Public health relevance
The parent project aims to understand how deaf children build a vocabulary in sign language, and whether and how this differs for deaf children who have limited exposure to a sign language. The goal of the supplement is to 1) increase the PI’s capacity to mentor scientists from diverse backgrounds, 2) create professional development materials for scientists in ASL, and offer training to a deaf postdoctoral researcher.